Delineation of the natural history of Ollier disease and Muffucci syndrome and investigation of their genetic bases

PROJECT SUMMARY/ABSTRACT
Ollier disease (OD) and Maffucci syndrome (MS) are untreatable, poorly characterized, newly recognized cancer
susceptibility syndromes. Their genetic bases and pathways responsible for the formation and progression of
benign and malignant tumors are not known. Our long-term goal is to identify pharmacological approaches to
treat bone deformities and malignant transformation in patients with OD and MS and to prevent/treat related non-
syndromic forms of cancers associated with these conditions. Our central hypothesis in this application is that
OD and MS are distinct under-characterized cancer susceptibility syndromes caused by variants in multiple
genes that disrupt the HIF-1 pathway. The rationale for our project is that phenotypic characterization and
identification of the genetic causes of OD and MS have the potential to offer a strong scientific framework
whereby new pharmacological strategies to cancer therapy in these patients and patients with the non-syndromic
forms of the same cancers, such as chondrosarcomas and gliomas, can be developed. The central hypothesis
will be tested by pursuing three specific aims: 1) Comprehensively define the phenotypic features of patients
with OD and MS; 2) Discover the causative genes and variants of OD and MS in previously uncharacterized
cases; 3) Determine the effect of causative variants of OD or MS in the HIF-1 pathway. We will pursue these
aims using an innovative combination of genomic and functional techniques applied to a unique set of deeply
phenotyped patients. The proposed research is significant because it will: 1) Define the natural history of novel
cancer susceptibility syndromes; 2) Establish a unique OD and MS germline and tumor sample collection for
research use; 3) Identify the genetic bases of untreatable cancers, and; 4) Determine the role of the HIF-1
pathway in OD and MS. Our expected outcomes are to define the responsible variants and genes that cause
benign and malignant tumor formation in OD and MS and to fully elucidate the phenotypic features and natural
history of these disorders. Our results will have an important positive impact providing new opportunities for the
development of novel pharmacological therapies to treat patients with these diseases as well as those with
related non-syndromic forms of cancers such as of chondrosarcomas and gliomas.

Public health relevance
PROJECT NARRATIVE The proposed research is relevant to public health because understanding what genes and pathways are responsible for the tumor formation in patients with OD and MS (untreatable diseases) and the degree to which they influence the medical outcomes related to cancer formation is expected to allow for more precise diagnosis of these patients and give rise to new types of treatments for patients with OD and MS and for patients with related, more common, non-syndromic forms of cancers such as chondrosarcomas and gliomas. Thus, this proposal is relevant to the part of NIH’s mission that pertains to fostering fundamental creative discoveries and innovative research strategies as a basis for ultimately protecting health.